CORE--CLINICAL

This core will identify patients and subjects, design data collection instruments, collect entry and institutional data on all subjects, be responsible for scheduling of patients for all procedures, and supervise data entry and analyses. It will also be responsible for ensuring screening laboratory procedures and skin tests are performed. The Clinical Core will also serve as a coordination source for communication among the investigators.